Kidney Transplantation from Donors with HIV: Impact on Rejection and Long-term Outcomes

Under the HIV Organ Policy Equity (HOPE) Act, early studies show that kidney transplantation (KT) from
donors with HIV to recipients with HIV (HIV D+/R+) expands the donor pool, reduces wait-times, and yields
excellent short-term patient and graft survival. However, significant rates of rejection were observed with a
trend towards higher rates in D+ recipients compared to HIV-uninfected donor (D-) recipients. Understanding
the impact of D+ on rejection, underlying mechanisms, and the impact on long-term outcomes is critical.
There are potential virologic and immunologic explanations for higher rejection in HIV D+/R+ vs D-/R+ KT. D+
kidneys harbor HIV and are more likely to harbor other co-infections such as CMV. These pathogens may
trigger an inflammatory response, enhancing T-cell or antibody(Ab)-mediated pathways of rejection.
Understanding the type of rejection and risk factors will inform interventions to improve outcomes, e.g. HIV D+
selection criteria, immunosuppression, or targeted monitoring and prophylaxis for co-infections.
We propose Expanding HOPE, a multicenter trial comparing outcomes in 100 HIV D+/R+ KT and 100 D-/R+
KT at 15 transplant centers. We will combine this cohort with prior cohorts of HIV D+ and D- KT from our
HOPE in Action Consortium, established in 2015. HOPE in Action has accrued approximately 325 HIV+ KT
recipients to date; this larger cohort provides sufficient statistical power to determine the impact of HIV D+
organ on rejection and it will also allow us to determine long-term patient and graft outcomes beyond 5 years.
Within this trial, we will perform comprehensive mechanistic studies to examine both T-cell and Ab-mediated
rejection pathways. We will quantify changes in donor-specific and viral-specific (HIV CMV) T cells using an
activated induced marker (AIM) assay in D+ and D- recipients, with and without rejection, over time. We will
perform TCRβ immunosequencing on sorted AIM+ cells vs unsorted T cells to track T cell receptor dynamics.
With VDJ-specific PCR, we will quantify expanded clones, including donor or viral AIM+ cells, post-KT.
We will also characterize inflammation and the humoral response to infections and human proteins (donor,
self). We will use a multiplexed electrochemiluminescence detection assay to quantify >30 cytokine and
chemokines to characterize inflammation, and phage display and immunoprecipitation sequencing to
characterize Abs to >1300 viruses, >14,000 microbial toxins/virulence factors, and >27,000 human autoAbs.
Our HOPE in Action Multicenter Consortium has an established track record, successfully completing
multicenter transplantation trials, including HIV D+/R+ KT. We will leverage our existing infrastructure to
oversee operations, data management, analysis, and safety monitoring.
In summary, the proposed research will determine the impact of HIV+ donor kidneys on rejection, will quantify
long term outcomes, and elucidate risks and mechanisms of rejection. This knowledge can improve and
expand HIV D+/R+ KT, and can provide important insights about alloimmunity more broadly.

Public health relevance
Under the HIV Organ Policy Equity (HOPE) Act, kidneys from donors with HIV can be used for transplant in recipients with HIV. Early studies of this practice demonstrate excellent short-term patient survival and survival of the transplanted organ; however, kidney rejection rates were high and long-term outcomes are unknown. This research will compare HIV+ and HIV- donor kidney transplant in HIV+ recipients in order to determine 1) the impact of HIV+ donor kidneys on rejection and 2) long term outcomes, and also includes scientific studies designed to improve our understanding of rejection in people with HIV and the general population.